Computational methods for detecting patterns of complex genomic variation

Project Summary
Rearrangements of genomic segments or structural variation (SVs), include changes (increase/decrease)
of copy number, inversions, translocations, and other mechanisms that change or rearrange the DNA
content of a cell. Complex SVs can mediate many constitutional diseases; highly pathological germline
rearrangements can damage the viability of the embryo; and somatic rearrangements can increase the
pathology of many diseases, including cancer.
The genomic footprint of complex SVs is a changed karyotype, deﬁned by a collection of sequences of
oriented genomic intervals whose coordinates are drawn from a reference genome, so that every sequence
corresponds to a haploid or marker chromosome. The goal of this renewal proposal is to develop tools to
elucidate the karyotype of a donor. In Aim 1, we will develop methods to reconstruct focal ampliﬁcations
using long-read technology. In Aim 2, we will develop methods to elucidate genome scale karyotypes for
constitutional disorders using optical genome maps. Highly rearranged regions will be clariﬁed using a mix
of experiments and computation in Aim 3. Finally, in Aim 4, we will extend the notion of a karyotype to
predict the 3-dimensional conformation of ecDNA using Hi-C. The development of our aims will require
novel graph theoretic and combinatorial optimization methods applied to new sequencing technologies.
Their successful implementation will provide novel algorithms and software tools for improved karyotyping,
deeper insights into gene regulation and DNA repair for focal ampliﬁcations, and better understanding of
disease pathology mediated by complex variations.

Public health relevance
Project Narrative Extensive rearrangement of genomic regions in an individual mediate many diseases but also pose chal- lenges for analysis. In this continuing grant, we develop computational algorithms to explain the complex rearrangements using new genomic technologies. The proposed methods will help detect and explain the pathology of constitutional genetic disorders and somatic DNA lesions observed in cancers.